Administrative Core

The Administrative Core will be led by Jeffrey Ravetch, M.D., Ph.D. (CCHI Director, Administrative Core Leader, and Project 1 Leader), who has space in the Laboratory of Molecular Genetics and Immunology at The Rockefeller University. The primary objectives of this Core are to provide administrative, compliance, and financial oversight, provide scientific direction, and create and facilitate clear and efficient communication to the entire CCHI. The role of the Administrative Core includes evaluating and coordinating progress in all four scientific projects by arranging meetings and other scientific exchanges, encouraging steamlined interactions with the proposed Service, Pilot, and Opportunity Fund Management Cores. The goals of the Core include 1) evaluating and coordinating progress on all four scientific projects, 2) establishing the External Scientific Advisory Group and disseminating recommendations for improvement or advancement, 3) creating and maintaining mechanisms for CCHI-related and field-related updates via a website, annual seminars, and monthly teleconferences, and 4) ensuring fiscal and compliance accountability throughout the life of the Center. The Administrative Core will also be responsible for coordinating internal and external leadership and advisory committees and assisting all investigators with manuscript preparation and annual progress reports. As part of the Administrative Core, a website will be built (linked to The Rockefeller University website) that gives updates, which will be available to the public, on progress and publications generated from the CCHI. The website will also include a password-protected component that will enable data dissemination to all projects to internal CCHI members. To encourage the ongoing exchange of ideas and information in the scientific field, the Administrative Core will also propose and manage an annual seminar held at The Rockefeller University.

Public health relevance
RELEVANCE (See instructions): Our program is highly integrated and is based on long-term, productive collaborations between the PIs aimed at defining underlying principles of human immunology. The Administrative Core will synergize the efforts and progress from the leadership team and will act as the coordinating center for the CCHI, establishing external committees and internal best practices.